A Mechanical Nanomembrane Detector for Time-of-Flight Mass Spectrometry

DESCRIPTION (provided by applicant): Existing detectors for time-of-flight (TOF) mass spectrometry of intact proteins in low charge states, such as microchannel plates and electron multipliers, rely upon the emission of secondary electrons for ion detection. Unfortunately, the efficiency of this secondary electron generation falls-off severely with increasing mass of the incident ions, dramatically reducing detection sensitivity and limiting the ability of TOF mass spectrometers to provide useful mass information on large biomolecules. This problem in ion detection is one of the major reasons that biological mass spectrometry as currently practiced is predominantly directed towards the analysis of small peptides rather than towards whole intact proteins, a critical limitation in the technology. We have developed a new type of ion detector to address this problem, based upon the mechanical deformation and vibration of a nanomembrane. An incoming ion packet initiates oscillations of the nanomembrane, which are then detected by corresponding oscillations in field emission electron current from the membrane. We propose here to develop our initial prototype detector into a powerful, robust, and well- characterized device for the mass spectrometry of intact proteins up to a megadalton in size. This new detector technology will open many new opportunities in biological mass spectrometry, in areas such as biomarker discovery and monitoring, the elucidation of protein variation, and the imaging of tissue by MALDI mass spectrometry. PUBLIC HEALTH RELEVANCE: This project seeks to develop a novel detector technology to dramatically improve the mass spectrometric analysis of intact high molecular weight proteins present at low abundance and/or in complex biological samples. Research in areas such as protein variation, biomarker discovery and mass spectrometric imaging will greatly benefit from this technology, opening new possibilities in the diagnosis and treatment of disease.

Public health relevance
This project seeks to develop a novel detector technology to dramatically improve the mass spectrometric analysis of intact high molecular weight proteins present at low abundance and/or in complex biological samples. Research in areas such as protein variation, biomarker discovery and mass spectrometric imaging will greatly benefit from this technology, opening new possibilities in the diagnosis and treatment of disease.